Reciprocal VEGFC/VEGFR3-CDH5 regulation of lymphatic and sinusoidal vascular growth

Project Summary
Sinusoidal and lymphatic vessel regeneration are predicted to improve treatment of
hematopoietic diseases and lymphedema, but are presently limited by an incomplete
understanding of the molecular and genetic pathways that control growth of these
specialized vascular beds. Prior studies by us and others have demonstrated that
VEGFC is required for fetal liver hematopoiesis, but a clear mechanism for this
requirement has not been identified. Our preliminary studies demonstrate that loss of
VEGFC/VEGFR3 function or gain of CDH5 function confers identical defects in
sinusoidal and lymphatic vascular growth. Further, our genetic studies demonstrate that
partial loss of CDH5 rescues both the anemia and edema conferred by the loss
sinusoidal and lymphatic vascular growth, respectively, in VEGFR3-deficient animals.
We hypothesize that a reciprocal VEGFC/VEGFR3-CDH5 regulatory loop controls
sinusoidal and lymphatic vascular growth. This proposal will test this hypothesis in vivo
and in vitro, investigate the molecular mechanism of this co-regulatory axis, and
determine whether manipulation of CDH5 can be used to stimulate sinusoidal and
lymphatic regeneration in mature animals. These studies are predicted to provide
fundamental new insights into sinusoidal and lymphatic vessel growth that may be
leveraged to treat patients with hematopoietic and lymphatic vascular diseases.

Public health relevance
Sinusoidal and lymphatic vessels are lined by distinct, VEGFR3-expressing endothelial cells, but the mechanisms by which these specialized vasculatures grow remain incompletely understood. Our preliminary studies reveal a reciprocal negative regulatory loop between VEGFC-VEGFR3 signaling and CDH5 function such that gain of CDH5 function confers loss of sinusoidal or lymphatic growth like that observed with loss of VEGFC or VEGFR3, and loss of CDH5 function enables growth of sinusoidal and lymphatic vessels in the complete absence of VEGFR3. This proposal will define the molecular mechanisms of this regulatory axis, and test the ability of CDH5 manipulation to enhance sinusoidal and lymphatic growth in mature animals to improve hematopoietic and lymphatic regeneration in disease states.